eHealth Supported Mindfulness-based Music Therapy Intervention (eMBMT) in Hemopoietic Stem Cell Transplant Patients

Allogeneic hematopoietic stem cell transplantation (allo-SCT) is a potentially curative procedure for many
hematologic malignancies. Due to the intensive conditioning regimen (e.g., radiotherapy, chemotherapy) and
post-transplant complications, allo-SCT is associated with multiple physical and psychological side effects
including symptom burden (e.g., fatigue, pain), and poor psychosocial function and emotional distress
(e.g., anxiety, depression) that impair health-related quality of life (HRQoL), and occur within the context
of following a strict self-management protocol to prevent treatment-related complications. Novel,
integrative, engaging, low-demand and scalable programs to reduce symptom burden and improve health related
quality of life (HRQoL) and health outcomes in allo-SCT are needed, yet limited work has addressed the
development and implementation music therapy—a therapeutic approach that can favorably impact health
outcomes in cancer survivors. Mindfulness-based music therapy (MBMT) blends core elements of
mindfulness and tailored music intervention components (e.g., songwriting, instrument playing) delivered by a
trained music therapist. Our transdisciplinary team has shown that (a) MBMT reduces negative mood, fatigue,
and anxiety in breast cancer survivors, (b) stress management and mindfulness improve physiological
adjustment (e.g., reduced inflammation) and HRQoL in various cancer survivorship populations, and (c) that
eHealth platforms can facilitate effective delivery of psychosocial interventions in cancer patients and survivors.
However, studies implementing the first step in developing and evaluating well-designed, feasible, acceptable,
and reproducible eHealth facilitated MBMT (eMBMT) interventions to improve patient outcomes are limited.
Further, how specific music therapy components impact psychosocial (e.g., anxiety, depression) and
physiological (e.g., inflammation, immunocompetence) mechanisms is not well understood. Using our
expertise in mix-methods approaches, eHealth, allo-SCT, and MBMT, we address these gaps and propose to
establish acceptability, feasibility and intended effects of a novel eHealth facilitated eMBMT in reducing symptom
burden and improving HRQoL (Primary Outcomes), improving psychosocial and physiological adaptation and
(e.g., cancer distress, reduced inflammation, T-cell recovery/immune reconstitution) (eMBMT Mechanisms),
and ameliorating disease activity (e.g., GVHD) (Secondary Outcomes) in patients undergoing allo-SCT. In the
R61 Phase we implement a mixed-methods (e.g., focus groups, small RCT) design to finalize eMBMT and a
mindfulness meditation (eMM) control condition, establish feasibility and begin to identify music therapy
components that favorably impact our study outcomes/mechanisms. In our R33 Phase we conduct a larger scale
pilot RCT informed by the R61 findings to establish intended effects of eMBMT music therapy components on
HRQOL, symptom burden and psychosocial and physiologic adaptation. Findings will guide a large-scale RCT
with long-term follow-up and additional clinical outcomes.

Public health relevance
Allogeneic hemopoietic stem cell transplant (allo-SCT) is associated with multiple physical side effects (e.g., fatigue, pain, diarrhea, nausea), and poor psychosocial function and emotional distress (e.g., anxiety, depression) that occur within the context of following a strict self-management protocol. Development of a behavioral and integrative intervention such as mindfulness-based music therapy—a therapeutic modality that has shown some promise in favorably impacting health outcomes in cancer survivors, and identifying specific music therapy components to favorably impact health outcomes may provide benefits to this and other compromised populations of cancer survivors. The development and delivery via eHealth of such interventions that are innovative, engaging and capitalize on the benefits of integrative medicine approaches have the potential to reduce critical and debilitating symptoms (e.g., pain, fatigue, sleep, cognitive function), improve health-related quality of life (HRQoL) and ameliorate disease activity in this and other compromised cancer populations.